Excitation-inhibition imbalance, posteromedial cortical dysconnectivity, and thought disorder in first-episode psychosis

PROJECT SUMMARY/ABSTRACT
This is an application for a K23 award for Dr. Michael Murphy, a psychiatrist and systems neuroscientist
at McLean Hospital and Harvard Medical School. The training objectives for this award are for the
candidate to (1) develop expertise in magnetic resonance spectroscopy (MRS) including integrating MRS
with electroencephalography data, (2) develop expertise in symptom assessment using psychometric
scales and deep-phenotyping, and (3) prepare the candidate for an independent research career. Dr.
Murphy has proposed a rigorous didactic curriculum as well as a skilled mentoring team including Dr.
Dost Ongur, Chief of the McLean Hospital Psychotic Disorders Division, as primary mentor.
Psychotic disorders (PDs) are severe psychiatric illnesses with poorly understood
pathophysiologies. Our understanding of these illnesses is limited both by a problematic syndrome-
based nosology and the technical limitations inherent in our neuroimaging and genetic techniques. These
disorders consist of multiple symptoms each of which may be driven by a distinct neural pathology and
which may change on its own timescale. Therefore, research that focuses on specific symptoms rather
than syndromes may be better able to ameliorate the limitations of current technology. Schizophrenia
has been proposed to be a dysconnection syndrome and given this hypothesis the symptoms of
schizophrenia may be caused by particular patterns of dysconnectivity. Thought disorder (TD) is a
commonly encountered symptom in psychotic disorders and is associated with poor prognosis. I propose
to test the hypothesis that TD arises from dysfunction within the thalamus and posteromedial cortex
(PMC) as well as dysconnectivity within cortico-thalamo-cortico loops involving the PMC. The proposed
dysconnectivity may partially decouple networks that maintain conscious awareness from those that
regulate attention. Inappropriate PMC connectivity will be tested with directional functional connectivity
which can distinguish between aberrant inputs to and outputs from the PMC, a distinction that would be
obscured in directionless measures. Functioning of neural circuits within the thalamus and PMC will be
assessed using MRS to assess levels of glutamate and GABA. The proposed project will test a novel
hypothesis linking neurochemistry, directed functional connectivity, and psychiatric symptomology. This
project will potentially provide a treatment biomarker which could be used to assess non-human models
of psychotic disorders and test treatment options.

Public health relevance
PROJECT NARRATIVE Thought disorder is a profoundly disabling, yet incompletely understood, cluster of symptoms that often affects individuals with psychotic disorders. This proposal seeks to use a longitudinal, symptom-based, and multimodal approach to test the hypothesis that periods of thought disorder are related to transient alterations of the relative balance of excitatory and inhibitory tone within the thalamus and posteromedial cortex as well as downstream dysconnectivity within corticothalamocortical loops involving these regions. Identification of the neural and neurochemical correlates of this thought disorder will lead to novel targets for therapeutic intervention and furthermore will produce a “treatment biomarker” that can inform the development of valid non-human models of psychotic disorders.